Mitochondrial Mechanisms of Astrogliosis in Epilesy

Project Summary
The goal of the parent grant is to determine the role of oxidative stress in astrocytic glial fibrillary acidic protein
(GFAP) upregulation. The supplemental research addresses a related but in depth mechanism to investigate the
role of GFAP and a related protein, vimentin in seizure-induced astrogliosis. Mitochondrial dysfunction, oxidative
stress and neuroinflammation are implicated as mediators of epilepsy and/or its comorbidities. The in depth
mechanisms underlying seizure-induced astrogliosis, particularly the upregulation of GFAP remain at large. We
have observed robust transcriptional upregulation of GFAP and vimentin in mice lacking the mitochondrial anti-
oxidant manganese superoxide dismutase-2 (Sod2) in forebrain neurons. The goal of these studies is to utilize
primary neuronal-glial cultures to determine the role of reactive cysteine residues in GFAP and vimentin as the
triggers for astrogliosis. Aim 1 will test the ability of two redox cycling compounds for their ability to activate
GFAP mRNA expression as a result of posttranslational redox modification of a conserved cysteines in GFAP
and vimentin. Studies will determine if neuronal and specifically mitochondrial ROS is sufficient to induce GFAP
upregulation and astrogliosis in vitro using mixed rat neuronal culture. Aim 2 will determine if upregulation of
GFAP and vimentin protein expression in mixed neuronal cultures occurs due to redox modification. These
studies could reveal mechanisms by which astrogliosis is initiated in neurological diseases such as epilepsy.

Public health relevance
Project Narrative The overarching goal of the supplement research is to obtain a detailed understanding of the role of oxidative stress in astrogliosis. The aims of the supplement address redox modifications of glial fibrillary acidic protein (GFAP) and vimentin after endogenous GFAP deletion. The studies can provide mechanistic insights regarding epilepsy-associated astrogliosis.